Structure/function analysis of understudied pH-sensitive Kir4.2 channels in vitro with conformation specific nanobodies

Project Summary Inward rectifying potassium (Kir) channels regulate excitability in many tissues, and multiple diseases result from mutations of Kir channel genes. The long-term goal of this project is to understand the molecular details of understudied pH-sensitive Kir4 sub-family channels. Previously, I defined molecular mechanisms of bulk anionic lipid regulation of Kir2 channels. These previous studies were made possible by my establishing a new expression system and purification protocols for eukaryotic Kir2 channels, as well as uniquely combining the multiple methods of (1) computational docking simulations, (2) functional assays of purified proteins reconstituted in synthetic liposomes, and (3) high resolution structure determination. These studies provide a template for gaining new understanding of understudied pH-sensitive Kir4 channels at the molecular level. We will establish an efficient expression system and a purification protocol for large scale purifications of Kir4.2 homo- and Kir4.2/Kir5.1 hetero-tetramer proteins that are understudied as well as develop nanobodies specific to functional states that will not only facilitate structure determinations in certain functional states but also have therapeutic potentials. Once established, we will utilize the same `triple combination' of approaches to determine molecular details of these understudied channel regulation and function.

Public health relevance
Narrative Inward rectifier potassium channels control excitability in many tissues and defects in these channels in humans lead to multiple diseases, including cardiac arrhythmias, diabetes, vascular dysfunction, epilepsy and other disorders of cell excitability. The novel approaches that we have uniquely developed put us in position to bring previously unobtainable insights to the molecular details of how these channels work. We will focus on one particular channel (Kir4.2) that has not been studied before using these approaches and will bring fundamental information for developing novel drugs or other approaches to treat human diseases resulting from dysfunction of these channels.